Noninvasive nanoparticle-directed therapy to the peripheral nervous system

PROJECT ABSTRACT
The blood-nerve barrier (BNB) is a highly selective boundary that often prevents the non-invasive delivery of
drugs to nerves, which is why nerve injuries and diseases remain difficult to treat1. The BNB highly limits the
non-invasive treatment of peripheral neuropathies, meaning that there are few treatments available depending
on the cause, despite severe cases that can result in debilitating nerve alterations. Even with traumatic peripheral
nerve injuries where regeneration spontaneously occurs, functional recovery is often very poor since
regeneration is abysmally slow. Current gold standard for addressing these traumatic nerve injuries involves
surgical interventions. However, even with these surgical interventions, most patients do not obtain functional
recovery if regeneration distances exceed a few centimeters. Here, we propose the design and
implementation of a local and systemically administered nerve-targeting polymersome platform that can
penetrate peripheral nerves and lead to functional recovery after peripheral nerve crush injury. We will
investigate the effect of adding two targeting ligands, Apolipoprotein E (ApoE) and Rabies Virus Glycoprotein
peptide RVG-9R, to the polymersome surface on BNB penetration. Preliminary data suggest that RVG-9R
enables delivery through the potentially injured blood-nerve barrier and ApoE is assists in the retaining
polymersomes in the nerve. We will elucidate the mechanisms associated with these ligand-based approaches
by studying alterations in receptor expression on the BNB and neural cells. We will study the pharmacokinetics
of ligated particles after sciatic nerve injury, correlating changing behavior with receptor expression. We will then
investigate the nerve regenerative effects of two different biologic drugs developed by co-I Jeff Twiss, a G3BP1
peptide and siRNA targeting prenyl-Cdc42 mRNA, delivered through polymersomes. This proposed work
represents a novel, potentially paradigm shifting approach to selectively deliver therapeutics to the peripheral
nervous system through non-invasive systemic injections, with the goal of enabling functional recovery post
nerve injury. However, the modular nature of the polymersome system and the ability to substitute various
therapeutic payloads enables the extensions of findings to acquired and inherited nerve diseases.

Public health relevance
PROJECT NARRATIVE It is difficult to treat diseases of the nerve without requiring surgery due to the presence of the blood-nerve barrier. Specifically with peripheral nerve injuries, surgery is also limited in its effectiveness due to the very slow nerve regeneration process. The overarching goal of this project is to develop nanoparticles to deliver therapy to the peripheral nerves through noninvasive administration to improve surgical outcomes and lead to functional recovery of the nerve. Findings could be used to develop other nanoparticle-based delivery systems for a variety of peripheral nervous system injuries and diseases.